LEGEND PLUS PACING SYSTEM, MODELS 8448/8448 PULSE GENERATOR

The purpose of the study is to determine the efficacy of the Legend Plus VVIR Pacemaker. This pacemaker has two activity sensors which determine the pacing rate during exercise. The GCRC protocol determines the utility of each sensor during normal daily activity.